Clinical Core

ABSTRACT: CLINICAL CORE
The Clinical Core (CC) supports ongoing and planned research programs at UAB, contributing to national
Alzheimer’s disease and related dementias (ADRD) research efforts. The CC focuses on clinical assessments
to support better understanding of ADRD risk factors especially prevalent in the Deep South. The CC has three
main products: (1) well-characterized participants referred to researchers in the ADRC including to the Imaging
Core and pre-consented autopsy cases for the Neuropathology Core, as well as the UAB and national ADRD
communities, (2) biofluid samples for genetic analysis and banking in the Neuropathology Core for sharing with
investigators, and (3) longitudinal clinical and functional outcome data to be made available through the Data
Management and Statistical (DMS) Core and the National Alzheimer’s Coordinating Center (NACC). Projected
enrollment will be ~525 new participants, with ~105 participants entering annually for each of the 5 years.
Cognitively unimpaired (N ~263), Mild Cognitive Impairment (N ~158) and mild dementia (N ~104) participants
will be preferentially engaged from community, rather than clinical, settings and followed annually. To
accelerate studies of health disparities in ADRD, Black or African American (B/AA) participants will be enrolled
at a proportion higher their frequency in the population of Alabama (≥40% vs. 23%). The NACC Uniform Data
Set, additional cognitive testing, assessments of social determinants of health (SDOH), body composition, and
actigraphic measures of activity will be collected, along with blood, CSF, and urine samples. Genotyping from
blood will be conducted and shared via NIAGADS. Biofluids will be aliquoted and stored for local researcher
access and sharing via NCRAD. All eligible subjects will be referred to the Imaging Core for structural and
molecular imaging (MRI, amyloid-PET, and tau-PET). A multidisciplinary Clinical Consensus Conference
determines clinical diagnoses. An innovative Biomarker Consensus Conference classifies individuals’ ATN
biomarker status while blinded to the clinical data and diagnoses. The CC will interact with all other UAB
ADRC Cores. It will function under the directives of the Administrative Core which oversees participant
referrals via the ADRC’s Protocol Review process. Retention of participants is done cooperatively with the
Outreach, Recruitment, and Engagement Core. CC data will be managed by the DMS Core, which in turn
provides formatted data summaries to the CC for Consensus diagnosis. Autopsy coordination and pre-consent
are managed by the CC on behalf of the Neuropathology Core’s Brain Donation Program. CC activities provide
training opportunities for Research Education Component learners.